Contribution of Levodopa to Brain Iron Accumulation

PROJECT SUMMARY/ABSTRACT
The antiparkinson drug levodopa (L-DOPA) is the current standard of treatment for Parkinson’s Disease
(PD) and can be used as either a monotherapy or in combination with monoamine oxidase-B (MAO-B) inhibitors,
such as selegiline to ameliorate dopamine depletion. Despite L-DOPA’s recognition as the gold standard for PD
management, our group has recently made a fundamental observation of iron accumulation in the substantia
nigra (SN) of PD patients following L-DOPA but not selegiline administration. These findings indicate that the
type of antiparkinson drug may be correlated with nigral iron increase. Evidence suggests that nigral iron
accumulation is increased in PD patients, decreasing dopamine thus exacerbating the progression of
neurodegeneration. Though, it remains unclear whether increased iron in the SN is from PD itself or from L-
DOPA treatment.
My objective for this proposal is to demonstrate that L-DOPA exposure alters the iron status through
direct effects on dysregulation at the BBB (Aim 1) and/or through altering the molecular and cellular profile in the
SN (Aim 2). Aim 1 of this project will elucidate how L-DOPA exposure will cause an increase in iron transport
from the blood-brain barrier (BBB) to the brain in an in vitro BBB model. I will measure iron transport in endothelial
cells after drug administration. Aim 2 will examine how L-DOPA delivered orally will impact the molecular,
histological landscape, and iron metabolism in the ventral midbrain. Furthermore, Aim 2 will take a unique
perspective to study how iron deficiency alters brain iron and exacerbate the severity of iron accumulation in a
rat model by examining brain iron levels and immunohistological staining expressions. PD patients have a high
prevalence of an anemic diagnosis, however, there is minimal research regarding the effects of L-DOPA and
anemia on brain iron homeostasis. This research project will deepen our understanding of how antiparkinson
treatments such as L-DOPA and selegiline impact iron homeostasis with the hopes of identifying iron-based
mechanisms from the treatment. Importantly, advances in iron supplements will provide novel therapeutic targets
to improve our standard of care for PD patients
The proposed training plan is sponsored by Dr. James Connor. The overall goal of the training plan is to
provide the fellowship applicant with a solid foundation for a successful career as a researcher and enhance
techniques for translational studies. The goals included in the training plan are 1.) Gain experience and
competence in various techniques integrating iron biology and neuroscience, 2.) collaborate with other research
scientists to learn and complement my knowledge, 3.) develop hypothesis-driven research, 4.) conduct
translational research, and 5.) effectively present data in a manuscript.

Public health relevance
PROJECT NARRATIVE Parkinson’s disease (PD) patients suffer from elevated levels of brain iron with levodopa (L-DOPA) commonly used by clinicians as a first-line antiparkinson drug. This project will research how our standard administration of L-DOPA impacts critical properties of iron homeostasis with the goal of identifying key iron mechanisms in the blood-brain barrier which will be confirmed by utilizing an in-vitro blood-brain barrier model and in-vivo murine model. This research will allow for the understanding of the mechanism of iron transport after L-DOPA exposure and target critical regulators to reduce brain iron accumulation and improve antiparkinson drug therapy development.